Structure and mechanism of mammalian ferroportin

Project Summary:
Ferroportin is the only iron exporter in humans. Mutations in ferroportin cause
hemochromatosis. Ferrorpotin is regulated by a peptide hormone hepcidin, which is
produced in the liver and inhibits the activity of ferrorportin by inducing endocytosis and
by direct inhibition of ferroportin activity. The FPN-hepcidin axis is a potential therapeutic
target for normalizing iron homeostasis in hemochromatosis. However, very little is
known about how ferroportin recognizes and transport iron and how it interacts with
hepcidin. In this study, I will combine structural and functional analyses to understand
the mechanism of iron transport and inhibition in ferroportin at the atomic resolution.

Public health relevance
Project Narrative: The trace element iron is a necessary nutrient needed for normal functions of myoglobin, hemoglobin, and many iron-containing redox enzymes. Ferroportin is the only iron exporter in humans and is the focus of the current proposal. I will investigate the structure and function of ferroportin and its regulation by a small peptide hormone hepcidin.